(OTHER FUNCTIONS) PRODUCE AND PUBLISH BBI JOURNAL SUPPLEMENT

Produce and Publish BBI (Brain, Behavior and Immunity) Supplement: Advances in Cancer and Brain, Behavior and Immunity: A Decade of Progress.